A novel approach for prevention of Bronchopulmonary dysplasia in at-risk pre-term infants

ABSTRACT
Bronchopulmonary Dysplasia (BPD) is the most common chronic respiratory disease in infants and is a
devastating condition that disrupts the developmental program of the lung secondary to preterm birth. BPD
affects neonates exposed to mechanical ventilation and, to date, there are no specific drugs available to prevent
or treat this life-threatening condition. The pathologic hallmarks of BPD are hyperoxia-induced pulmonary
inflammation, increased cell death, dysregulated angiogenic factors culminating in impaired alveolarization,
dysregulated vascularization of the lung and pulmonary hypertension. AyuVis Research, Inc, is developing a
novel class of low molecular weight natural oligosaccharide-derived small molecules which activate macrophage
to a non-inflammatory phenotype via TLR4 signalling. Our lead candidate AVR-48 binds to TLR4 resulting in
selective activation of the target cell to block inflammatory mediators in lung and upregulation of endogenous
vascularization pathways improving lung vascularization leading to improved lung function. AVR-48 has a
glucosamine core, making it responsive to O-GlcNAcylation of serine/threonine of lung proteins, a conserved
defense against injury that enables cellular remodeling. Additionaly, it enhances production of certain host anti-
inflammatory molecule such as IL-10 and growth factor VEGF with vascularization effects remaining local to
lungs. We have demonstrated that intraperitoneal injection of AVR-48 prevents hyperoxia-induced BPD in a
neonatal mice pup model at 10mg/kg dose and intravenous injection in invasive mechanical ventilator induced
BPD in pre-term lambs at 0.3mg/kg-3.0 mg/kg doses. In order to advance the lead candidate AVR-48, AyuVis is
proposing three complimentary aims: (1) Determine safety and long-term efficacy in the preterm lamb model by
testing whether prophylactic treatment with AVR-48 improves the long-term respiratory, cardiac and
neurodevelopmental outcomes measured after 2 months of life to mimic 1-2 years of infant life; (2) Demonstrate
anti-inflammatory effect of AVR-48 in human cord blood after hyperoxia challenge by measuring cytotoxicity,
inflammatory and anti-inflammatory mediators and macrophages; and (3) Determine toxicokinetic parameters in
juvenile rats that will be used to model human equivalent dose in clinic. These studies are expected to provide
mechanistic and confirmatory efficacy data which would enable AVR-48 to progress to GMP manufacturing and
file an Investigational New Drug application.

Public health relevance
NARRATIVE Bronchopulmunary Dysplasia (BPD) is a disease of pre-term infants whose lungs are injured upon exposure to excess oxygen from ventilators, impairing effective gas exchange in the lungs. Ayuvis Research is developing a novel class of immunomodulating compounds derived from chitin that decrease inflammation and improve lung vascularization as well as decrease pulmonary hypertension. Our objective is to test the efficacy of our lead compound in pre-term lamb model mimicking the physiology of preterm ventilated human newborns and to further validate its effect in a series of animal and in vitro tests. Results of this research could lead to much- needed prophylactic treatment for BPD and treatment for other life-threatening lung conditions.